Hematopoietic and Immune Development in the Human Chorion

Project Summary/Abstract: Hematopoiesis occurs at multiple sites during human prenatal development. In
addition to the primary intraembryonic hematopoietic tissues, it is now recognized that the extra-embryonic
tissues – the placenta and chorion – contain hematopoietic stem cells. The presence of hematopoietic stem
cells in these tissues raises the possibility that they actively contribute to the pool of blood cells contained in
the extra-embryonic tissues. In this proposal we focus on the human fetal membranes, specifically the chorion.
Macrophages are present in the chorion and presumably act as sentinels and first responders to infection as
well as invasion by maternal cells. The presence of these macrophages suggests that the chorion is not just an
inert physical barrier. We hypothesize that the human chorion is an immunologically active barrier containing
macrophages that develop in situ from hematopoietic stem cells that together with other cells in the chorion
maintain the maternal-fetal interface to prevent infection and immune rejection of the fetus during pregnancy.
In the first of three specific aims, we will investigate if chorionic hematopoietic stem cells serve as a local
source of precursors for monocytic cells found in the chorion. Tissues across a range of gestational ages will
be examined using flow cytometry, hematopoietic progenitor cultures, and a transplant model, using
immunodeficient mice, to determine the types of hematopoietic precursors that exist in the chorion.
Experiments will focus on demonstrating active myelopoiesis in the chorion. In the second aim, we will explore
the role of the chorionic microenvironment in the development and function of macrophages. Mesenchymal
stromal cells and cytotrophoblasts comprise the hematopoietic niche in the chorion, which will be studied in
culture to test their effects on monocyte development and macrophage maturation. We hypothesize that these
cell types support the development of M2 macrophages to foster an anti-inflammatory environment in the
chorion. This will be more specifically tested in the third aim, in which we will investigate the
immunomodulatory role of chorion cells in preventing rejection by maternal T-cells. Preliminary data show the
presence of T cells in the chorion of both maternal and fetal origin. The origins and distribution of T-cells in the
chorion will be further investigated at different gestations. Additionally, we will determine if the T-cells are
active and if they are enriched in any specific T-cell subtypes. T-cells from the adjacent decidua will be
analyzed for comparison as well as fetal T-cells from the spleen. We will explore the roles of chorionic
macrophages, mesenchymal stromal cells, and cytotrophoblasts in the regulation of T-cell activation. Together
these aims will show that chorionic macrophages develop locally from a population of stem cells in the chorion.
Also, that these macrophages, in conjunction to other cell cellular populations contribute to generate an active
immunological barrier at the extensive maternal-fetal interface that includes the fetal membranes, which
function to ward off infection and invasion of maternal lymphocytes.

Public health relevance
Project Narrative: This proposal examines the role of the human chorion as an active site of blood cell production. The development of macrophages from hematopoietic stem cells in the chorion and their role in providing immunity will be investigated. Results from this study will provide insight into conditions such as chronic chorioamnionitis that threaten pregnancy and may lead to fetal demise.